Advanced development of multi-omics based assays to predict late radiation organinjuries - the DEARE-Watch project

Abstract
Groundbreaking research has led to the successful development of countermeasures against acute radiation
toxicity, thereby significantly increasing the chance of survival of victims of a radiological accident. However,
survivors of acute radiation syndrome (ARS) are at risk for developing delayed pathologies to vital organs such
as the lung and kidney in the ensuing months to years after exposure. This is evidenced in victims of accidental
radiation exposures, where radiation-induced lung injury has been reported in more than 50% of exposed victims.
Additionally, in a cohort analysis of Japanese atomic bomb survivors, radiation dose was significantly associated
with progressive chronic kidney disease. Therefore, the availability of FDA-approved predictive algorithms for
risk assessment of late radiation injury remains an urgent and unmet need for managing a radiological
emergency. Minimally invasive biomarkers that predict the development of radiation injuries in particular organ
systems would enable targeted disease monitoring and early therapeutic interventions that minimize radiation
induced degenerative effects on tissues and organs. Our previous work with rodent models of partial body X-ray
or γ-ray exposures led to the development of liquid chromatography-mass spectrometry-based multi-omics
panels that, when dysregulated in plasma and urine within the first month after irradiation predict late injury to
the lung (LungWatch) and kidney (KidneyWatch) with high specificity and sensitivity. However, further studies
are needed to enable wider implementation of these predictive biomarker panels. The goal of this application is
to expand our biomarker panels for use in understudied populations and incorporate these, together with
software for analysis and visualization of risk into prototype LungWatch and KidneyWatch devices, to present to
the FDA. Using our well-characterized WAG/RijCmcr rat model of total and partial body irradiation, we will
determine the impact of treatment with an FDA-approved ARS mitigator, radiation type (X-ray and γ-rays) and
age (adult and juvenile) on the performance of the LungWatch panel in plasma and KidneyWatch panel in urine
(Aim 1). Subsequently, we will validate the plasma and urine panels in irradiated non-human primates and
establish baseline thresholds of the biomarkers in samples that represent the general human population, to
enable unambiguous risk classification in humans (Aim 2). These rigorous biomarker studies along with the
development of new algorithms for companion software required for automated analysis and interpretation of
biomarker data, will allow us to develop target product profiles and documentation for FDA biomarker
qualification for KidneyWatch and LungWatch device(s) (Aim 3). Taken together, we will develop kit-based multi-
omics assays with automated classification algorithms that are amenable to high-throughput screening, to
distinguish between individuals with and without elevated risk of radiation induced lung or kidney injury after a
mass casualty event.

Public health relevance
Project Narrative In cases of radiological or nuclear incidents, there is a need for accurate and sensitive methods to determine which individuals may develop radiation injuries, and in which organs. The lung and kidney are two organs at risk for injuries that become clinically apparent months to years after radiation exposure. This project aims to develop the first FDA-approved biomarker assays in blood plasma and urine that can predict the development of radiation injury in the lung and kidney, for use in victims of a radiological or nuclear event.